Simultaneous MRI/US for real-time liver ablation guidance and confirmation

Project Summary:
Percutaneous liver tumor ablation procedures are performed with ultrasound (US), computed tomography (CT)
and CT-fluoroscopy guidance. Each image guidance modality has strengths and weakness. US provides
superior tissue contrast and real-time guidance; however, suboptimal or absent acoustic windows, motion
(respiratory, bulk), and poor applicator conspicuity compromise precise tumor targeting and a widening skill
gap limit widespread adoption. The larger field-of-view (FOV) provided by CT is critical for evaluating proximity
of non-target anatomy; however, poor tissue contrast, limited access along the X-Y-Z axis, motion, and non-
real-time guidance limit accurate tumor targeting. Magnetic resonance imaging (MRI) provides superior soft
tissue contrast but presents challenges with the comparatively long acquisition times for real-time guidance
and limited access within the scanner bore. Image fusion technologies attempt to harness the strengths of
each modality. Unfortunately, current image fusion technologies are unable to sufficiently account for liver
deformation, bulk respiratory and patient motion which compromise targeting. Further, they do not address
challenges associated with US. An Academic Industrial Partnership is proposed to develop and validate a
solution comprised of two primary elements. The first is a combined platform with a novel MRI compatible
hands-free US and fast 3D deformable image registration for optimized simultaneous US and virtual MR image
guidance in the ablation setting. The second element will be development of advanced MRI methods for real-
time treatment monitoring through MR Thermometry in combination with near-real-time assessment of ablation
zone margins using advanced diffusion and perfusion MRI. This solution will improve primary efficacy and
reduce local recurrence after ablation of liver tumors. This proposal will focus on microwave ablation however
the solution is applicable for a wide variety of thermal therapies.

Public health relevance
Project Narrative: Current approaches to guiding percutaneous liver ablation have significant limitations yielding poor tumor control rates. This multi-disciplinary, multi-institutional Academic Industrial Partnership will develop and validate a simultaneous US and MR solution in combination with advanced MR methods for real-time guidance, treatment monitoring and margin assessment during liver ablations with the ultimate goal of improving patient outcomes.